Vermont Immunobiology / Infectious Diseases Center

PROJECT SUMMARY/ABSTRACT Influenza virus epidemics cause significant morbidity and mortality each year. Host determinants of infection severity and pathogenesis remain poorly defined. Sex differences in influenza infection outcomes are well documented, but not well understood mechanistically. Our previous funding from NIAID and VCIID COBRE has enabled us to conduct a genome wide screen of host genetic determinants of influenza virus pathogenesis, using a unique genetic model of natural genetic variation in mice. Our screen has identified two loci, one on chromosome 5 and the other on chromosome X, that significantly modify sex differences in influenza pathogenesis. We propose to begin a dissection of the mechanisms underlying these genetically regulated sex differences. Additionally, we will extend these studies to include young pre-pubertal mice.

Public health relevance
PROJECT NARRATIVE Infection with influenza A virus (IAV) poses a serious public health problem every year. It important to understand why different people have more or less severe outcomes of infection. Our proposed studies will improve our understanding of existing differences in severity of infection in women vs. men.